Nephronophthisis-related ciliopathies and ciliary specialization

Project Summary
Cilia play essential roles in human development and health. Ciliary ubiquity and diversity are reflected
in multi-symptom ciliopathies caused by ciliary defects. The clinical severity of ciliopathy gene mutations varies
between cell types and includes cystic kidney disease, neurological and skeletal defects, retinal degeneration,
situs inversus, and male infertility. While the same basic intraflagellar transport (IFT) machinery constructs all
cilia and flagella, the mechanisms underlying ciliary specialization are poorly understood. For example, cilia
produce extracellular vesicles (EVs). Whether EV shedding is a general property of cilia or a specialized
feature of some cilia types is unknown. The functions of ciliary EVs and their contributions to ciliopathies are
also poorly understood. The long-term goal of this project is to identify molecular mechanisms regulating ciliary
specialization, remodeling, plasticity, EV biogenesis, and EV functions. Cilia of the C. elegans inner labial-type
2 (IL2) neurons display several specializations: they have unique microtubule ultrastructure, specialized IFT,
and shed EVs. The IL2 ciliary transition zone (TZ) and axoneme is structurally plastic and remodels from one
structure to another during animal development: from a canonical 9+0 to non-canonical 6+0 structure. While
cilia and flagella share a 9-fold microtubule doublet symmetry, variations in microtubule numbers are observed
in nature. Renal primary cilia do not conform to the 9 + 0 paradigm. This developmental plasticity suggests that
some ciliary defects (ciliopathies) may be corrected at later times. Our hypothesis is supported by the recent
discovery that autosomal dominant polycystic kidney disease is reversible, and that the kidney displays
structural plasticity. Our simple C. elegans model allows us to uncover mechanisms that regulate ciliary
remodeling and plasticity. We found that TZ remodeling requires IFT and the tubulin code – combinatorial use
of tubulin isotypes, glutamylation, and microtubule-associated proteins. Nephronophthisis-related ciliopathies
(NPHP-RCs) are associated with defects in TZ-associated proteins. NPHP-RCs include nephronophthisis,
Meckel Gruber (MKS), Joubert (JBTS), and Senior-Løken syndromes. The clinical severity of loss of function of
NPHP-RC genes varies between cell and cilia types, thus it is imperative to understand ciliary and EV biology
in a variety of contexts. We will use C. elegans to identify mechanisms driving transition zone and axonemal
remodeling and plasticity in non-canonical primary cilia. Ciliary EV shedding is a conserved, yet little is known
about how and why cilia make EVs. We will test the hypotheses that ciliary remodeling and a non-canonical
structure impacts EV biogenesis and EV function.

Public health relevance
Project Narrative Cilia are found on most non-dividing cells in the body, perform many functions, and when faulty, cause human diseases called ciliopathies. In nephronophthisis-related ciliopathies (NPHP-RCs), mutations in a single gene can cause different disease spectrums (renal, neurological, skeletal, retinal, cardiac, and other abnormalities), indicating the importance of understanding ciliary specialization. The application uses the C. elegans model system to identify conserved mechanisms regulating ciliary specialization, remodeling, and plasticity, which important therapeutic implications as cilia are found on nearly every non-dividing cell in the human body.